Interrogating the molecular architecture of the Cryptosporidium host-parasite interface

ABSTRACT
Cryptosporidium infections are a leading cause of diarrheal disease in young children for which no
vaccine or universally effective treatment is available. Apicomplexan parasites such as Cryptosporidium,
Toxoplasma, and Plasmodium actively invade their host cells and reside within a specialized membrane-bound
compartment, or parasitophorous vacuole (PV). To survive and replicate, intracellular parasites must evade
immune detection and extract nutrients from the host cytosol. Toxoplasma and Plasmodium secrete the contents
of specialized secretory organelles, such as dense granules, to the PV where they orchestrate vacuole
remodeling and immune evasion, while solute transporters at the parasite plasma membrane import small
molecules such as amino acids and sugars. In addition, a conserved Kelch13-containing complex in these
parasites is responsible for the formation of specialized membrane invaginations in the parasite plasma
membrane that facilitate nutrient extraction from the host by bulk endocytosis.
Cryptosporidium resides in a unique intracellular but extra-cytoplasmic niche. Transmission electron
microscopy of intracellular Cryptosporidium revealed intricate ultrastructural features at the host-parasite
interface, including electron dense bands, tight junction-like rings, and a highly invaginated membrane termed
the feeder organelle. The three-dimensional architecture, composition, and function of these features are poorly
understood. Recent studies and preliminary data have identified a handful of proteins that localize to the C.
parvum host-parasite interface, including secreted effectors and solute transporters. The relationship between
these components to each other, to the host cytosol, and to the ultrastructural features observed at the interface
are unknown. In addition, the machinery responsible for shaping the membrane invaginations at the feeder
organelle has not been identified.
I hypothesize that transporters and secreted effectors occupy separate compartments at the interface,
with transporters assembled in the parasite plasma membrane and effectors delivered to the PV membrane or
lumen. I will uncover the three-dimensional ultrastructure, molecular architecture, and composition of the host-
parasite interface at unprecedented resolution using cryogenic electron-microscopy-based volume imaging
techniques. I will also use high-resolution optical microscopy and fluorescence complementation to determine
whether transporters and dense granule effectors are trafficked to the same compartment. I also propose that
the feeder organelle is shaped by K13 complex-mediated endocytosis, and I will determine the localization of
these candidates in intracellular C. parvum parasites using light and electron microscopy. These studies will
leverage innovative structural and molecular parasitology approaches to reveal mechanisms of membrane
remodeling and nutrient acquisition fundamental to the biology of intracellular parasitism, yielding insights that
will aid the rational design of therapeutics to combat this important disease.

Public health relevance
PROJECT NARRATIVE Diarrheal disease caused by the parasite Cryptosporidium causes significant death and disability mainly in young children and immune compromised adults. This single-celled parasite takes up residence in and manipulates cells of the intestine to extract nutrients and avoid destruction by the immune system. Our work will reveal the molecular machines used by Cryptosporidium to accomplish these feats, which will help to identify suitable targets for the development of life-saving vaccines and treatments for this disease.